Hybrid TMS/MRI system for regionally tailored causal mapping of human cortical circuits and connectivity

Project Summary.
We propose a new coil array that will enable next-generation causal brain mapping with unprecedented flexibility,
resolution and precision. The proposed ARES2 hybrid array generates E-fields in the cortex for transcranial mag-
netic stimulation (TMS) as well as B-fields for spatial and diffusion encoding applications including high-resolu-
tion, high b-value diffusion MRI and fMRI. Multi-channel TMS allows different cortical targets to be probed either
sequentially or simultaneously, providing a flexible tool for modulating brain activity that is imaged concurrently
with MRI. By virtue of their close proximity to the head, the coil elements will provide a large boost in diffusion
MRI encoding in the cortex beyond what is possible with current MRI gradient technology, enabling improved
sensitivity to mapping neuronal and dendritic sizes and their distribution following targeted neuromodulation and
providing sub-millimeter spatial resolution for BOLD-fMRI in the cortex following stimulation.
In Aim1, we will test a 3-channel prototype of the proposed head array, ARES2 (Array for Reception, Encoding,
Shimming, and Stimulation) by leveraging our recent developments in MR-compatible transcranial magnetic
stimulation (TMS) coils. The coils will be driven by large currents to yield 1000 mT/m max. gradients and high
slew rates. The parallel design comprising 48 encoding coils permit B0-shimming capability, while 28 radiofre-
quency coils interlaced with the encoding coils provide parallel imaging. Custom drive amplifiers and switching
electronics will allow alternation between “stimulation” and “imaging” modes. A comprehensive electronic control
system will allow arbitrary waveforms to be played out on all channels in sync with the scanner’s pulse sequence.
In Aim2, we will scale the system up to the full 48-ch array. We build a new TMS-compatible 28-ch RF receive
array that is mechanically integrated with a TMS probe holder device. The TMS probe holder will allow radial
adjustment of the TMS probe to allow it to be placed against the head surface.
In Aim3, we will apply the system in vivo to perform next-generation causal brain mapping at submillimeter
resolution. We will demonstrate ARES2’s ability to provide regionally specific measures of cell body (soma) and
neurite size and density in the motor (M1) and somatosensory cortex (S1). These diffusion MRI experiments will
make use of gSlider volumetric diffusion encoding to boost SNR and reach submillimeter resolution. For TMS-
fMRI, we will use the 9ch TMS and 48ch MRI gradient system in an interleaved manner for successive stimulation
and fMRI recording in M1 and S1.

Public health relevance
Project Narrative We propose novel hardware and data acquisition strategies for next-generation causal mapping of the human cerebral cortex using transcranial magnetic stimulation (TMS) and high-resolution MRI. Leveraging our recent developments in MR-compatible TMS coils, we will develop a hybrid brain array of 48 coils for both TMS and noninvasive imaging that will be used to probe and map structural and functional changes in the living human brain at an unprecedented level of detail.